Rapid Intraoperative Fluorescence Assessment of Nerve Damage

PROJECT SUMMARY
Acute peripheral nerve crush injuries frequently result from closed or open fractures, joint dislocations, and high-
energy collisions. Nerve compression can lead to functional deficits ranging from paresthesias to complete motor
and sensory function loss, affecting ~1.6 million trauma patients annually. Assessment of the degree of injury
and the possibility for functional recovery versus the need for amputation or complete nerve transfer after injury
remains challenging and to date no objective methodology exists to aid in immediate decision-making at the time
of injury. Scoring systems have been developed with threshold values for amputation, however their utility to
date has been inconclusive. Thus, surgeons are left to make nerve damage assessments via gross visual
examination, which cannot resolve the degree of axonal disruptions and/or tissue degradation, leaving ~50% of
patients with poor functional recovery outcomes. We hypothesize that fluorescence guided surgery (FGS) using
a nerve-specific fluorophore could provide an objective methodology to determine the degree and recoverability
of nerve injury, guiding surgical intervention. Over the past 10 years, our group has worked on the development
of nerve-specific fluorescent contrast to improve intraoperative nerve visualization. We have developed a library
of first-in-kind, small molecule, targeted, near-infrared (NIR) fluorophores that label nerve tissue with high affinity,
which are currently undergoing preclinical pharmacology and toxicology testing for first-in-human (FIH) clinical
trials. These fluorophores provide nerve visualization with high contrast at millimeter to centimeter tissue depths
in mice, rats and swine facilitating clear identification between healthy and injured nerve tissues following
topical/paint-on or systemic administration. We propose to fully characterize the fluorescent uptake profiles and
intensity differences seen between healthy and damaged nerve tissue using our NIR nerve-specific fluorophores
to provide an objective methodology for intraoperative nerve damage assessment. This study’s immediate
milestones will include (1) selection of an optimal imaging time point for the nerve damage assessment
methodology, (2) quantification of fluorescence intensity, nerve to surrounding tissue ratios and uptake
parameters in healthy, permanently damaged, and recovering nerve tissue in mouse sciatic nerve injury models
and (3) validation of the developed nerve damage assessment methodology in a blinded mouse sciatic nerve
injury study for future clinical translation. We will leverage the expertise of our team in nerve contrast agent
development, nerve-specificity quantification, pharmacology assessment and nerve injury models to complete
the following: Aim 1: Develop a nerve damage assessment methodology to objectively guide surgical decisions.
Aim 2: Validate the most predictive nerve damage assessment methodology in a blinded study for future clinical
translation. Completion of these studies will result in the first objective nerve damage assessment methodology
for trauma surgery utilizing novel NIR nerve-specific fluorophores developed by our team. The proposed method
development and validation will provide important proof-of-concept for future clinical translation.

Public health relevance
PROJECT NARRATIVE Acute peripheral nerve injuries are the common result of closed or open fractures, joint dislocations, and high energy collisions, which can lead to functional deficits ranging from paresthesias to complete motor and sensory function loss. Assessment of the degree of injury and the possibility for functional reconstruction versus the need for amputation after injury remains challenging and to date no objective methodology exists to aid in decision making during orthopaedic trauma surgery. In the proposed studies, we will develop a nerve damage assessment methodology using our novel near-infrared, nerve-specific fluorophores for fluorescence guided surgery to facilitate objective assessment of the degree of nerve injury and the potential for recovery to guide orthopaedic trauma surgery for complex peripheral nerve injuries.